Breastfeeding Education Support Tool for Baby

PROJECT SUMMARY
Optimal infant feeding practices, including exclusive breastfeeding (EBF) for 6 months, play a critical role in
determining the health, growth, and development of children, yet a large portion of infants in India lack the
benefit of optimal feeding practices. Community-based programs directed at improving feeding practices of
mothers in India are needed.
The objective of this application is to conduct an effectiveness-implementation hybrid type I trial of our
Breastfeeding Education Support Tool for Baby (BEST4Baby) intervention. BEST4Baby consists of prenatal
and post-delivery breastfeeding education and support for mothers provided by community-based peer
counselors who are trained in a 5-day WHO/UNICEF Breastfeeding Counselling Course and supported by an
mHealth application. In Aims 1 and 2, we will test the effect of BEST4Baby on EBF for 6 months, infant growth
velocity, and infant neurodevelopment. A cluster randomized controlled trial will be conducted in 4 sites across
Karnataka State, India, with 16 Primary Health Subcenters (i.e., “clusters”) within each site randomized in a 1:1
ratio to one of two study arms (usual care [control] or BEST4Baby [intervention]). Eighteen pregnant women in
each of the clusters (N=1,152) will receive either routine health education during the prenatal and postnatal
period or 11 in-person BEST4Baby intervention visits (2 during pregnancy, 9 post-delivery) from peer-
counselors. All participants will be followed longitudinally until their infants are 12 months of age to test the
effect of assigned study arm on outcomes. In Aim 3, the RE-AIM framework and the Consolidate Framework
for Implementation Research will guide our mixed-methods approach to evaluate BEST4Baby’s
implementation and to identify implementation facilitators and barriers to inform sustainability and future
adoption. Completion of this study will fill an evidence gap by demonstrating whether BEST4Baby is an
effective mechanism to improve maternal behaviors and whether this intervention translates to improved
clinical outcomes in infants. Findings from this project will also provide evidence needed to implement
BEST4Baby across India and in other low resource communities.
This project is guided by NICHD’s mission to enhance the lives of children. It aligns with four of NICHD’s
cross-cutting scientific priorities - health disparities, disease prevention, nutrition, and global health - as well as
NICHD’s Pediatric Growth and Nutrition Branch as BEST4Baby is aimed at promoting health during infancy, a
critical period in human development. Given the lack of comprehensive prenatal and post-delivery
breastfeeding support within the current India healthcare system and that India contributes one-fifth of all
global live births, improving infant feeding practices of mothers in India, and thus improving infant health, could
have major public and global health implications and we anticipate this research will be of significant impact.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to evaluate the effectiveness and implementation of the Breastfeeding Education Support Tool for Baby (BEST4Baby) intervention, an mHealth-supported community-based peer counselor breastfeeding intervention for mothers in India. Given that rates of optimal infant feeding practices have remained stagnant over the past two decades in India, and that India is the most populous country and icontributes one-fifth of all global live births, this project could have major global health implications if the intervention is found to improve maternal breastfeeding practices and infant clinical outcomes. The project will also provide evidence needed to adopt BEST4Baby nationally and in other low resource communities.